The Maintenance of Human Atrial Fibrillation

DESCRIPTION (provided by applicant): Atrial fibrillation (AF) is the most prevalent heart rhythm disorder in the U.S., affecting 2-5 million individuals in whom it may cause stroke, palpitations, heart failure, and even death. Unfortunately, therapy for AF is limited. Anti-arrhythmic or rate-controlling drugs are poorly tolerated, with frequent side effects and do not reduce stroke risk. Ablation is an emerging minimally invasive therapy that has attracted considerable attention because it may eliminate AF. Unfortunately, AF ablation is technically challenging, with a success of only 50-70 % (versus >90% for other arrhythmias), and serious risks. A major cause of these limitations is that the mechanisms for human AF are not known and thus ablation cannot be directed to them. As a result, AF ablation is empiric and results in extensive destruction of the atrium. In this Mid-Career Mentoring Award in Patient Oriented Research, the applicant proposes a mentored training program for clinician-scientists, applying bioengineering principles to address mechanistic hypotheses on the maintenance of human AF. From a training perspective, each mentee will receive continuous mentoring by the applicant and an interdisciplinary research committee comprising experts in heart rhythm medicine, bioengineering, computer modeling and biological physics. Through formalized collaborations, mentees will also be able to train in cellular electrophysiology. Structured didactic training is also outlined. Scientifically, our central hypothesis is that human AF is maintained by localized sources, as opposed to widely dispersed mechanisms (multi-wavelet reentry). We will create detailed maps of atrial activation and recovery (repolarization) in AF in patients at ablation, and then use computational analysis and pharmacologic interventions in near-real-time to study mechanisms that maintain AF. Personalized computer models will be unique in that predictions will be tested directly against observed AF in the same patient, with discrepancies used to directly design further clinical studies. Because the project is performed at ablation, results will be easily translated to practice. The candidate has a track-record of using bioengineering principles, signal processing and computer models to address mechanistic hypotheses in arrhythmia-focused patient oriented research. He also has a track record of training clinician-scientists who continue to pursue patient oriented research, many of whom have secured extramural funding. Proposed studies address three Aims: 1) To determine if localized sources maintain human AF; 2) To determine if repolarization alternant, conduction slowing or anatomic factors explain disorganization to fibrillation; 3) to determine the impact on AF of ablating at potential localized sources. Successful completion of our Aims will lead to a paradigm-change in the mechanistic understanding of human AF, and approaches to its ablation. Mentees will be trained in a rich interdisciplinary environment and, on completing this program, will be well prepared to embark upon careers in patient-oriented research in heart rhythm disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: fibrillation (AF) is an enormous public health problem that affects 2-5 million Americans, causing morbidity or death from stroke, rapid heartbeats and heart failure. Through this Mid-Career Mentoring Award in Patient Oriented Research, the applicant will perform research and train junior physician-researchers to better understand AF, and determine if abnormal activity in small regions or more widespread regions of the heart cause AF. By performing these studies in patients during clinical procedures, this project may lead to a paradigm-shift in understanding and treating AF. Narrative Atrial fibrillation (AF) is an enormous public health problem that affects 2-5 million Americans, causing morbidity or death from stroke, rapid heart beats and heart failure. Through this Mid-Career Mentoring Award in Patient Oriented Research, the applicant will perform research and train junior physician-researchers to better understand AF, and determine if abnormal activity in small regions or more widespread regions of the heart cause AF. By performing these studies in patients during clinical procedures, this project may lead to a paradigm-shift in understanding and treating AF. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Atrial fibrillation (AF) is the most common heart rhythm disorder in the U.S. that afflicts 2.2 million Americans 44 45. However, despite major clinical and basic science advances, AF still leads to an increased risk of stroke, heart failure, dementia 46, hospitalization, impaired quality of life and death 47. AF ablation is a minimally invasive therapy that has attracted much interest because of its potential to eliminate AF 48, 49, unlike medical therapy that is often ineffective and poorly tolerated 50, 51. However, AF ablation is challenging even for experts52. Ablation may eliminate AF, particularly paroxysmal AF, yet overall one-procedure success is only 50-75 % at 1 year 9 with a 5-10 % risk of complications 53 including death 54. A central perplexing enigma of AF 9 is that AF mechanisms are rarely identified, and thus very difficult to target for ablation. As a result, AF ablation is empiric and extensive, that may contribute to its suboptimal success, technical difficulty and risks. One leading mechanistic hypothesis for the maintenance of AF is multiwavelet reentry 9, 55, in which multiple wavelets co-exist, migrate and extinguish, motivating the multiple incisions or lesions of current surgical 56 and ablation 9 to interrupt these wavelets. An alternative hypothesis is that localized sources maintain AF 11, as observed by HaWssaguerre et al. near the pulmonary veins in paroxysmal AF 11. In this case, localized ablation should be effective. However, localized sources have not been identified 4 in the larger number of patients with persistent AF, despite elegant experiments in animal models showing that localized 'electrical rotors' 4 or repetitive focal beats 21 sustain AF. This proposal is based upon our discovery of electrical rotors and repetitive focal beats in human AF, where focused ablation terminated AF acutely in a pilot study supporting their mechanistic role. We hypothesize that human AF may be sustained by electrical rotors or focal beats and that, when present, the extent of tissue they organize (space constant) and disorganization to AF (fibrillatory conduction) are determined by repolarization dynamics and conduction slowing. We have 3 Aims: 1. Aim 1. To establish whether rotors or repetitive focal activations, when observed, contribute mechanistically to human AF by determining if beat-to-beat variations in rate determine fluctuations in neighboring tissue, with and without agents to terminate or facilitate AF. We will analyze activation temporospatially at >100 simultaneous bi-atrial electrodes at EP study in patients with paroxysmal and persistent AF and in controls with atrial tachycardias. 2. Aim 2. To determine whether the extent of atrium organized by observed rotors or focal beats (space constant), and the zone of disorganization (fibrillatory conduction) are determined by APD oscillations and conduction slowing rather than location. We will use patient-specific computer models created from monophasic action potentials and activation isochrones in the zone of disorganization and computed tomography (CT). This will be repeated with and without agents that flatten APD restitution or slow conduction. 3. Aim 3. To show that, when AF electrical rotors or focal beats are observed, targeting them for ablation acutely terminates AF if their space constant is above a cutpoint that we will determine, from receiver operating characteristic analysis in patients with persistent and paroxysmal AF during clinical ablation. This proposal has broad scientific and clinical significance. Our novel methods and Preliminary Data make these among the earliest studies of localized electrical rotors and repetitive focal activations in human AF. This will enable us to address whether and how often human AF is mechanistically sustained by these sources or by multiwavelet reentry, and whether these mechanisms can be differentiated in individual patients. We will use state-of-the-art computer models that will become a generalized resource. Accordingly, our results will have great significance for AF diagnosis, management and ablation. A Glossary of Terms used in this Proposal is provided in the Appendix.